The role of bidirectional transport of lysosome-related organelles in learning and memorystorage

Project Summary/ Abstract
Axonal transport, the movement of cargoes such as organelles between the cell body and the synapse,
is key for transporting signals and cargoes that mediate plasticity. Cargoes that undergo bidirectional axonal
transport include mitochondrion, which is essential for providing energy to the cell and maintaining neuronal
functions, and lysosome-related organelles (LROs), which are necessary for protein degradation and recycling
and neuronal health. Yet, the regulation of organelle transport during synaptic plasticity is poorly understood.
To fill our gap and understand the role and regulation of axonal transport during learning and memory, I
will investigate mitochondrial and LROs axonal transport in Aplysia pre-synaptic sensory neurons and post-
synaptic L7 motor neuron during excitatory and inhibitory synaptic plasticity and long-term memory. The central
hypothesis underlying this proposal is that excitatory plasticity negatively regulates the flux of LRO transport
whereas inhibitory plasticity upregulates it in pre- and post-synaptic neurons. I will test my hypothesis with
three aims. My first aim will determine whether long-term synaptic facilitation and depression regulates
bidirectional transport of LROs in pre- and postsynaptic neurons and, assess the transport dynamics of LROs
using photo-switchable Dronpa-Lysosome-20. My second aim will investigate the role of biogenesis of
lysosome-related organelle complex 1 subunit-2 (BLOC1S2) in regulating the flux of LRO transport during
long-term synaptic facilitation. The third aim will assess the role of ApBLOC1S2 in sensitization of Aplysia.
Scripps Florida and Florida Atlantic University provide the optimal environment and the necessary
resources to accomplish the goals of this proposal and fostering my career development. Moreover, my
sponsors are eminent neuroscientists, guidance from Dr. Sathya Puthanveettil will support my project progress
and career development. Co-sponsor Dr. Ryohei Yasuda’s imaging expertise will me to develop the technical
capabilities to utilize photo-switchable Dronpa-Lysosome-20 plasmid and photo-bleaching techniques to study
the LROs anterograde and retrograde transport dynamics as described in aim 1. Cosponsor Dr. Ronald Davis
is a leader in the field of learning and memory and will help me develop the skills to rigorously assess my data,
interpret my findings, and its application, especially when assessing opposing plasticity-types (excitatory and
inhibitory long-term plasticity) in my aim 2. Lastly, cosponsor Dr. Robert Hawkins is a leader in behavioral
learning in Aplysia, therefore, his guidance and training will be key for my success in assessing the role of
ApBLOC1S2 in learning and memory mentioned in aim 3. My findings will be presented at international
conferences such as Max Planck Florida Institute’s Bi-Annual Synapse conference, the Society for
Neuroscience meeting, Cold Spring Harbor meetings and Gordon Research Conferences. The aims, trainings,
and tools proposed in this grant will help contribute to my goal of becoming a Principal Investigator to study
long-term memory storage and add to our knowledge of learning, memory, and neurodegenerative diseases.

Public health relevance
Project Narrative Learning and memory are one of the most essential actions for life, thus revealing their components could lead to ways to protect it from neurodegeneration and expand its efficiency. Lysosome-related organelles are acidic, membrane-bound organelles that are involved in digesting macromolecules and are transported bidirectionally along the axon in neurons. It is unclear whether the transport of these organelles is regulated during learning and memory, thus this proposal aims to reveal the role and regulation of lysosome-related organelles transport during excitatory and inhibitory synaptic plasticity in Aplysia californica.